Combined Training Program in Digestive Disease Sciences

This application requests continuation of funding for a Combined Training Program in Digestive Disease
Sciences (CTPDDS). The overall goal of the program is to train qualified individuals with a MD, PhD, MD/PhD
or equivalent degree committed to a research career in the broad field of digestive health sciences. The program
will educate such individuals in a comprehensive fashion so that, upon completing the program, they will be able
to excel as independent investigators and successfully compete for funding at the national level. The foundation
of the proposed program is based on the strategic planning, consolidated efforts and close academic integration
of the Departments of Gastroenterology, Hepatology & Nutrition at the Cleveland Clinic and Case Western
Reserve University as well as affiliated basic science Departments at both institutions. The recruited faculty
enjoys a reputation of academic excellence based on superior clinical, translational and basic research, ample
funding from the NIH, and has a combined research space in excess of 100,000 square feet. A unique aspect of
the program is its Multiple PD/PI approach, which allows research to span departmental boundaries and enlist a
variety of mentors with a tradition of highly productive collaborations who have trained a large number of young
investigators in an effective interdisciplinary manner. Nearly 40 Mentors and Co-Mentors from 13
Departments/Programs, representing a wide range of scientific interest and expertise at both institutions, are
prepared to offer a variety of training opportunities that will be tailored to the scientific interest and career goals
of each trainee. The specific expertise and main research areas of the preceptors will include Inflammatory
Bowel Disease/Mucosal Immunology, Gut Microbiome and Metabolic Disease, Gastrointestinal Oncology, Liver
Disease, and Genetics. In addition to the resources available in the laboratories of individual Mentors, the
trainees will take advantage of the combined rich scientific environment of the Cleveland Clinic and Case
Western Reserve University. This application seeks 4 post-doctoral positions in year 1, and 4 new trainee
positions in each of the subsequent years during a projected total funding period of 5 years. Each successful
applicant will be trained for a minimum period of two years by the institutional grant.

Public health relevance
Project Narrative Diseases of the gastrointestinal tract, liver and pancreas affect a large proportion of humanity, imposing a major burden on cost, productivity and quality of life. The overreaching goal of the proposed program is to educate a variety of health professionals with a doctorate degree to help improve digestive health in the population al large. By expanding the number of physicians and investigators the program will foster the discovery of new and more effective forms of treatment for digestive diseases.